An AI-based empathic virtual companion to track changing health states in persons living with dementia

PROJECT ABSTRACT
Mentia, a company focused on improving the lives of people with dementia through meaningful
engagement with interactive technology, addresses the health inequity of the nation’s 6.8 million dementia
population compared to non-ADRD older adults. This group is twice as likely to have multiple chronic
conditions than non-AD/ADRD older adults, and health management is complicated by memory,
communication, and sensing deficits, contributing to a 2.5 times greater likelihood of visiting Emergency
Departments. Once there, patients commonly experience disorientation and anxiety in a stressful, unfamiliar
environment, and may experience polypharmacy, excessive testing, and potential hospital admission, which
may hasten their cognitive and functional decline. These cascading effects come at great cost to patients, their
families, and the healthcare system, with Medicare alone spending $100 billion annually more on seniors with
dementia than seniors without.
To stem the humanistic and economic crises, we propose a new system for the early detection of acute
health events that enables patients to receive timely clinical care in place. Our solution, known as
MentiaCompanion™, leverages AI and Mentia’s deep understanding of the engagement process for people
who live with AD/ADRD, to track the person’s health state, enabling connected care and clinical health teams
to assess risk. The system, to be developed in two phases, is a technology for data collection (Phase I) and
the alignment of data sets with health risk assessment (Phase II). Preparatory work on this solution was
undertaken in 2021-23 via an NIH SBIR grant and an NIA subaward via Johns Hopkins University's Artificial
Intelligence and Technology Collaboratory for Aging (AITC).
The goal of Phase I is to achieve frequency of use. Based on the principle that high engagement
equates to frequency, Mentia Companion will run autonomously to relieve caregiver load, while empathic and
knowledgeable on-screen avatars will hold informed two-way conversations by processing speech and emotion
recognition, life stories, and case notes. Mentia Companion will serve both verbal and non-verbal users,
exceeding usual chatbot offerings. Further engagement will be achieved through avatar-led activities within a
dementia-friendly virtual world. The avatars will guide users through media-rich environments containing
meaningful interactive stimuli based on non-pharmacologic approaches to care.
A user experience (UX) study to identify optimal ways to start and complete sessions autonomously,
along with AI technology development, will culminate in an AD/ADRD cohort study to establish that we have
the frequency of use needed to build the data sets in the Phase 2 work that follows.

Public health relevance
PROJECT NARRATIVE To curb the human and economic cost of AD/ADRD, Mentia is developing an AI-driven engagement system that is easy to access and use autonomously by people living with AD/ADRD with a wide range of cognitive and physical abilities. While providing social benefits to AD/ADRD users and work benefits to caregivers, this system MentiaCompanionTM will collect relevant physical, cognitive, and behavioral data and early health observational data during usage. This data, in a later stage, will support early detection of health risks, such that more often people with AD/ADRD can be treated earlier, in their known safe environment rather than necessarily in emergency departments and hospitals.